Task C12: Infectivity and Lethality of Filovirus strain(s) in NHP

This contract provides for the development and standardization of non-human primate models for infectious diseases, and may include efficacy testing of candidate products, including GLP studies to support licensure.